Training Program in Immunology

PROJECT SUMMARY/ABSTRACT
This T32 training grant renewal application is to support the training of 6 predoctoral and 4 postdoctoral
trainees in Immunology. Training is to be performed at 3 institutions: The University of Colorado Anschutz
Medical Campus (UCD-AMC), the Barbara Davis Center for Childhood Diabetes (BDC; at AMC), and National
Jewish Health (NJH). All training faculty are primary or secondary members of the UC-AMC Department of
Immunology & Microbiology. There are 43 faculty trainers and similar in number to our last renewal application
in 2015. This cohort of faculty provide expertise in both basic, human and translational immunology.
The grant will be directed by two Program Directors, Dr. Raul Torres and Dr. Ross Kedl, whose
laboratories are both located at UC-AMC. This arrangement is to ensure appropriate attention is directed to
both predoctoral and postdoctoral trainees. Dr. Torres is a well-known B cell biologist who has had continuous
NIH funding for over 20 years and has successfully trained a number of graduate students that have gone on
to secure positions as faculty, in biotech, journal editor and strong academic postdoctoral positions. He has
been the PI on this T32 for the previous 5 years. Dr. Kedl has successfully trained a number of predoctoral and
postdoctoral fellows that also currently occupy (tenure-track) faculty and biotech positions. He was the
Associate Director of the Ph.D. training program in immunology at UC-AMC for almost 10 years and is well
known for his work on T cells. Responsibility for various aspects of the Training Grant will be shared by these
two PDs as described in the Multiple PD Leadership Plan.
Trainees will be selected for support by the Program Steering Committee after application by trainee
and mentor. Selection will be based on the merit of their previous work and their proposal for future research
and appointments will typically be for 2 years. Trainees are required to take Responsible Conduct in Research
every 4 years, to attend and present in our weekly “Research in Progress” forum and to complete each year an
Individual Development Plan that is discussed with their mentor. Evaluation of progress of research and
advice about career direction will be provided for predoctoral students by their Thesis Committee and for
postdoctoral fellows by a mentoring committee consisting of at least 3 faculty members, chosen by the fellow.
Predoctoral and postdoctoral trainees must meet their committees at least once every 6 months, and the
committees must submit written reports describing the meetings.
This Training Grant has a long and distinguished record, with almost all of its trainees going on to
successful careers as scientists, ranging from academia to public service at NIH or the CDC to research in
Biotech or with big Pharmaceutical companies. Particularly notable is its continued successful recruitment and
training of a number of underrepresented minorities. The Program continues to be a major focus for
immunological research in the Rocky Mountain region in particular and the USA in general.

Public health relevance
PROJECT NARRATIVE Immune responses protect us from infections but on the other hand can be destructive, leading to autoimmune diseases such as type I diabetes or rheumatoid arthritis or allergic responses such as asthma. Although, during the last 50 years, a tremendous amount has been learned about the immune response still much remains to be discovered. Thus, the goal of this Grant is to train predoctoral and postdoctoral fellows in further research on the basic mechanisms of the immune response, and application of such training to translational research.